PRECLINICAL MEDICATIONS SCREENING IN DEPENDENCE MODELS OF ALCOHOL USE DISORDER. BASE CONTRACT PLUS 4 OPTIONS THROUGH 8/15/2024. BASE PERIOD: 08/16/19 - 08/15/20; (PERIOD 1 FY-19 FUNDING)) PERIOD 1.

alcohol